Precision Deaminases to Expand the Scope of Diseases Amenable to CRISPR-mediated Correction

PROJECT SUMMARY
The ability to install precise genetic changes is a longstanding goal in biology. While there are over 6,000 known
disorders with monogenic origins, estimates are that only 10% of these are currently treatable. Most genetic
variants associated with disease are single point mutations which are potentially correctable via systems that
exchange a single DNA base (base editors). Base editors treat point mutations by appending a deaminase
enzyme that catalyzes single nucleotide changes to a programmable DNA binding protein (Cas9) that localizes
the editor to its target. This technology has seen overwhelming success with adenine base editors (ABEs)
entering the clinic within just five years of their initial report. Notably, ABEs do not generate double-stranded
breaks, making them an ideal candidate for genome editing—especially in stem cells which suffer low genome
editing efficiency and large rearrangements or deletions in DNA in response to DNA cleavage. The correction of
point mutations in the genomes of stem cells has the potential to provide essential cell-based therapies for
immunodeficiency and neurodegenerative diseases. However, the capacity of this approach is limited by editing
promiscuity at neighboring bases. This constrains target selection to a narrow range of mutations where nearby
off-target edits would not negate the effect of the edit or induce additional pathogenic mutations. For instance,
mutations causing severe combined immunodeficiency (SCID) and Hurler syndrome are potentially reversible
by adenine targeting base editors, yet inaccessible by current methods due to the proximity of another editable
adenine bases to the target site. Therefore, there is an unmet clinical need for the advent of precision editors
capable of precisely targeting mutations in hematopoietic stem and progenitor cells (HSPCs) to produce edited
cells for autologous transplantation. My proposal describes a two-pronged approach to developing precision
base editors that both extends existing technology and creates an entirely new kind of editing enzyme with
intrinsic properties that prevent off-target edits. Our approach provides key insights into genome editing
mechanisms that can be harnessed for treatment of a wide range of diseases.

Public health relevance
PROJECT NARRATIVE Most genetic variants associated with disease are single point mutations which are potentially correctable via systems that exchange a single DNA base (base editors). However, the capacity of this approach is limited by editing promiscuity at neighboring bases which constrains target selection to a narrow range of mutations where nearby off-target edits would not negate the effect of the edit or induce additional pathogenic mutations. This proposal addresses an unmet clinical need for the advent of precision editors using a two-pronged approach that extends existing technology and creates an entirely new kind of editing enzyme with intrinsic properties that prevent off-target edits.